Role of advanced glycation end products (AGEs) in primary open angle glaucoma

PROJECT SUMMARY
Glaucoma is the second leading cause of blindness, characterized by progressive damage to the optic nerve.
About 80 million people are globally affected by this disease, and nearly 11 million are blind from it. Primary
open-angle glaucoma (POAG) is the most common type and accounts for up to 80% of all glaucoma cases. It
is characterized by an open, normal-appearing anterior chamber angle and elevated intraocular pressure (IOP)
with no specific ocular abnormalities. The elevation of IOP, a significant and only modifiable risk factor in
POAG, is due to the greater resistance of the drainage system. About 80–90% of aqueous humor exits the eye
via the trabecular meshwork (TM). TM cells synthesize and secrete extracellular matrix (ECM) proteins, which
have negligible turnover and accumulate chemical modifications during aging. The overarching hypothesis of
this proposal is that the accumulation of advanced glycation end products (AGEs) in TM promotes ECM protein
synthesis by the TM cells and causes resistance to AH outflow in POAG. This hypothesis will be tested by the
following two specific aims. In Aim 1, we will test the hypothesis that AGEs in the TM lead to ECM remodeling
and TM cell dysfunction. To test this, we will compare AGE levels in TM tissues from POAG patients and
controls, examine AGE-induced ECM and cellular changes, perform RNA sequencing to identify affected
signaling pathways, and assess the therapeutic potential of an AGE receptor antagonist. In Aim 2, we will
investigate whether increasing AGE levels in TM contributes to increased outflow resistance and IOP
elevation, using a sustained-release system to deliver AGE precursors into mouse eyes. By targeting AGE
receptor utilizing a receptor antagonist treatment or receptor-deficient mice, we will explore the therapeutic
potential of targeting AGE-RAGE interaction to mitigate TM damage and reduce outflow resistance. The
proposed project is expected to uncover a novel mechanism for aqueous outflow resistance, and the findings
could lead to innovative therapies to reduce IOP in POAG.

Public health relevance
PROJECT NARRATIVE Despite many advances in clinical and basic science, primary open-angle glaucoma remains a major vision- threatening disease. This proposed study will investigate the role of advanced glycation end products in the trabecular meshwork, which contribute to increased aqueous humor outflow resistance and elevated intraocular pressure. The findings may lead to innovative therapies to prevent ocular hypertension and potentially preserve vision in POAG patients.